Training in Signature Transdisciplinary Cardiovascular Sciences

PROJECT SUMMARY/ABSTRACT
This is the first renewal for our T32 postdoctoral program (3-year duration, requesting to maintain our 6
positions/year) for MDs, DOs, PharmDs, and PhDs at the Medical College of Wisconsin’s Cardiovascular
Center. Building on our successes with 36% of appointees from underrepresented groups and 100% of
graduates (n=5) with further NIH funding (2 K99s, K01, F32, etc.), innovative new components include
diversification of leadership, a refined, more diverse group of faculty mentors, a new academic course, and
novel collaborations with campus centers to enhance translational science. With strong institutional support
and excellence in cardiovascular research, we leverage multi-PI leadership, the recent renewal of a Clinical
and Translational Science Award, a new American Heart Association Strategically Focused Research
Network award, and philanthropic support to fund trainee recruitment and enrich training. The Directors are
established physicians and scientists with extensive administrative experience who, along with 30 basic
scientists and translational investigators, serve as mentors. Our training program is scaffolded by a highly
integrated collaborative well-resourced research environment with a 360-degree evaluation system
surrounding our Signature Programs, specific areas of scientific excellence in 1) atherosclerosis,
thrombosis, and vascular biology, 2) cardiac biology and heart failure, 3) precision cardiovascular medicine,
and 4) hypertension. Our program emphasizes critical components designed to launch/sustain independent
research careers: 1) 3 years of support to enable grant (re)submissions, 2) individualized development plans
(IDP), 3) protected research time, 4) multidisciplinary mentoring teams, 5) training in core competencies ,
and 6) industry/biotechnology or scientific liaison career options for trainees not pursuing a traditional career
in academia. A rigorous nationwide selection process aids in our diverse trainee selection and team
mentoring is optimized using innovative tools (e.g., DiSC® and career path assessments). The IDP includes
foundational elements of progressive responsibility, coordination across multiple levels of translation,
interactions with cardiovascular and non-cardiovascular scientists, near-peer learning opportunities, specific
coursework, seminars, and conferences. Our long-term benchmark/goal is for more than 50% of our
postdoctoral trainees to transition into competitive faculty positions within 3 to 5 years of exiting our program.
Our intermediate benchmarks include publications, presentations, and grant submissio ns. Along with the
Directors, an Executive Committee and External Advisory Committee that have extensive experience with
career development, leadership, and directing training grants all provide program oversight and monitor
trainee progress every 6 and 12 months. Overall, the ultimate goal of our training program is to train the
next generation of cardiovascular scientists and physicians, including underrepresented groups in science
and medicine, by incorporating broad-based, personalized, supportive, and rigorous training opportunities.

Public health relevance
PROJECT NARRATIVE This is the first renewal for T32 postdoctoral training support of MDs, PharmDs, and PhDs which leverages institutional strengths and scientific excellence in atherosclerosis, thrombosis, and vascular biology, cardiac biology and heart failure, precision cardiovascular medicine, and hypertension research. Our commitment for excellence in research training is demonstrated by 36% of appointees coming from underrepresented groups and 100% of graduates with further federal funding and has foundations in the core values of diversity, mentorship, and improved health outcomes by training the next generation of cardiovascular scientists and physicians, including those from underrepresented groups, through broad-based, personalized, supportive, and rigorous training opportunities. At a time when the burden of cardiovascular disease continues to rise and the pipeline of investigators, especially clinicians dwindles, our training program is designed to invigorate the recruitment and development of those who will make the next series of advances in research to improve cardiovascular health.